Development Core-Population Dynamics Research Center

Development Core Project Summary
Our proposed Development Core promotes (a) activities across the academic year, designed for professional
and institutional integration, and scientific advancement; (b) mentoring, as a way of motivating and inculcating
good scientific and professional habits across professional generations; and (c) a program for pilot research
projects—a program targeted at promising research ideas that is also a mechanism for socializing early career
scientists into the process of seeking competitive funding. We use a combination of existing and new colloquia
and workshops to create a rich intellectual and scientific environment that dovetails with the exigencies of
junior faculty life. We focus on activities that are both desirable and feasible, in the sense that they enhance
the work-time of early career scholars and do not detract or distract from it. Because there are now so many
more people involved—the Penn PSC has recently recruited a large, promising groups of new assistant
professors—the potential benefits of each activity are increased via synergy (as well as aggregation).

Public health relevance
Development Core Project Narrative The proposed Development Core is a highly efficient mechanism for multiplying the value of existing resources, those sought under this application, and inputs external to this award. The Development Core at the Penn PSC reflects the success of the Center in convincing our colleagues and the University administration to (re)invest in early career population scientists. Activities proposed in this core build on and fuel a strong early career scientist base being supported at Penn.